AHA Hypertension Scientific Sessions

Project Summary
More than fifty percent of adults and children in the United States suffer from high arterial pressure
(hypertension). If left untreated, hypertension can cause cardiovascular disease, kidney damage, and stroke.
The purpose of this application is to request travel funds to support trainees who wish to attend and participate
in the Hypertension Scientific Sessions 2024 to be held September 5-8, 2024 in Chicago, IL. Hypertension
Scientific Sessions is the preeminent conference on hypertension, and is organized by two Councils of the
American Heart Association: The Council on Hypertension and the Council on Kidney in Cardiovascular Disease.
This meeting is considered one of the most important and prestigious meetings focused on hypertension. The
conference includes oral and poster presentations selected from abstracts submitted by clinical and basic
researchers, followed by discussions facilitated by leading experts in their respective fields. Attendees will have
the opportunity to interact closely with experts from around the world involved in cross disciplinary research in
hypertension, cardiac and kidney disease, genetics, stroke, and obesity. This meeting will offer sessions
specifically designed to benefit trainees and early career investigators. In addition, the meeting offers Clinical
Practice topics focused on applying clinical science and improving patient outcomes for primary care providers.
By supporting the travel, education, and development of promising early-career scientists, we hope to expand
and diversify the current workforce, thereby ultimately increasing the innovation of hypertension research. The
specific aims of 2024 Hypertension Scientific Sessions and this application are: 1) Provide early career attendees
with a forum to present their research and obtain constructive feedback from a knowledgeable international
audience of scientists working in the field of hypertension; 2) Encourage trainees to enhance their current
knowledge by attending state-of-the-art and cutting-edge symposia and lectures organized by the Planning
Committee of the Hypertension Scientific Sessions; 3) Offer trainees an opportunity to network with their peers
and senior scientists in the area of hypertension; and 4) To increase the participation of speakers and moderators
from Historically Marginalized communities (HMCs). This award will multiply the participation of researchers from
HMCs, trainees, and early career scientists, in a welcoming environment devoted to learning the latest advances
in the field of hypertension.

Public health relevance
Project Narrative More than fifty percent of adults and children in the United States suffer from have high arterial blood pressure (hypertension); if left untreated, hypertension leads to cardiovascular and kidney disease and stroke. The purpose of this application is to request travel and caregiver funds to support trainees and junior investigators who wish to attend and participate in the Hypertension Scientific Sessions 2024 to be held in Chicago on September 5–8, 2024. By supporting the travel, education, and development of these promising early-career scientists to this preeminent meeting, we hope to expand and diversify the current workforce, ultimately increasing innovation in hypertension research.